Explore the role of hepatocyte inflammasome in alcoholic liver disease

Project Summary/Abstract
Alcohol-Associated
with
are
kidney
regulated
1
all
the
inflammasome
inflammasomes,
essentially
epithelial-targeted
indicating
revealed
alcohol
hand,
hepatocytes r
treatment.
mitochondrial
PPARα
and
cell
the
for
features
inhibiting
beneficial
Liver Disease (AALD) is the leading cause of liver-related deaths in the USA. AALD starts
lipid deposition in hepatocytes and progresses to liver inflammation and fibrosis. Effective treatment options
very limited. There are t hree clinical trials ongoing in humans targeting IL-1β signaling. In these studies,
toxicity was reported, indicating that liver-specific approaches should be considered. IL-1β production is
upstream by the assembly of inflammasome components [an inflammasome adaptor ASC, caspase-
or caspase-11, and i nflammasome sensors (NLRs or NLRCs)]. nflammasome components are expressed in
l iver cell types, and to date, we have very limited nowledge of the effect of inflammasomes in hepatocytes,
most abundant liver cell type and an important driver of AALD pathophysiology. I t was reported that the
was activated in hepatocytes upon alcohol exposure. To further explore the liver-specific role of
we deleted one essential inflammasome component, caspase-1 (Casp1), common to
all inflammasomes, in liver epithelial cells specifically using Albumin-Cre mice. We found that liver
deletion of Casp1 leads to a strong exacerbation of the disease in the NIAAA alcohol model,
a rotective role of Casp1 gainst AALD in the l iver. Liver bulk RNA-seq and proteomic analysis
that in the absence of Casp1 from hepatocytes, the antioxidant defense mechanisms in mitochondria,
detoxification, NF-κB-related pathways and myeloid-driven inflammation are reduced. On the other
fatty acid synthesis and PPARα target genes are increased. In vitro experiments in Casp1-deficient
evealed exacerbation of mitochondrial ROS production and cell death upon alcohol and LPS
In Aim 1, we will examine which hepatocyte cell-intrinsic pathway is affected by Casp1 related to
ROS production, alcohol metabolism, and lipid deposition. We will focus on NF-κB, β-catenin, and
revealed by omics analysis. We will also examine if the Casp1 effect is due to IL-1β or IL-18 production
signaling. In Aim 2, we will delete Casp1 or Casp11 in hepatocytes and examine liver pathology and immune
alterations after 8 weeks of alcohol feeding. The results generated from this project will provide the basis for
preparation of an R01 application to study which molecule from inflammasome sensors is the best candidate
targeting in vivo in regular mice and in humanized mice with alcohol that we have een to recapitulate several
of human AALD. These results will help in the design of better therapeutic approaches in humans by
inflammasome function in the ell types where it has a clear pathogenic role while preserving the
functions of the inflammasome.
I
k
p a
,
s
c

Public health relevance
Alcohol Associated Liver Disease (AALD) is the primary cause of liver related deaths in USA. Hepatocyte express all the components of inflammasome, but we don't know their role in this very abundant and important liver cell type. We have seen exacerbation of the disease upon Caspase- 1 deletion in hepatocytes. We are proposing to explore in which step of alcohol metabolism and its's subsequent lipid accumulation and toxicity, the hepatocyte inflammasome molecules are involved.